Role of TREX1 in age-related hereditary leukoencephalopathy

Project Abstract
The goal of this proposal is to define the mechanisms of retinal vasculopathy with cerebral leukoencephalopathy
(RVCL), an adult-onset vascular dementia associated with brain atrophy, blindness, and premature death,
usually within 5-10 years of disease onset. RVCL is an autosomal dominant disease that is refractory to treatment
with immunosuppression despite the fact that RVCL patients develop autoantibodies. RVCL-causing mutations
in the TREX1 gene cause disease with 100% penetrance. Currently, there is no effective treatment for this
devastating disease, and the mechanisms of disease pathogenesis have not yet been defined.
Dr. Jonathan Miner (PI) directs the RVCL Research Center at the University of Pennsylvania and coordinates
care of RVCL patients from around the United States and the world. Dr. Miner also leads a team of RVCL-
focused clinicians and investigators. Preliminarily the Miner laboratory has generated numerous mouse and
human cellular models of RVCL and discovered novel molecular mechanisms that may be driving
endotheliopathy, cellular senescence, and the resulting vascular dementia. The co-investigator is Dr. Nouri
Neamati, a medicinal chemist and biochemist at the University of Michigan. Dr. Neamati is developing TREX1
inhibitors and protein degraders. This partnership has led to novel animal models, single-cell RNA-seq studies,
and first-in-class inhibitors of TREX1, as well as our discovery that RVCL-causing TREX1 mutations lead to
failure of replicative senescence and dysregulation of endogenous retroelements.
Here, we propose to use cellular and animal models to define the role of TREX1 in regulating DNA damage,
retroelements, and pathology (Aim 1), to use animal models to define functions of TREX1 mutants and a DNA
damage repair pathway in humoral immunity (Aim 2), and to determine the role of TREX1 DNase activity using
an enzyme-dead TREX1 mutant mice and first-in-class TREX1 inhibitors and protein degraders (Aim 3). Our
mechanistic studies will broadly elucidate functions of TREX1 and the role of TREX1-mediated DNA damage in
a mouse model expressing TREX1 mutants known to cause small vessel disease and vascular dementia in
humans. Insights gained from our work may clarify the role of TREX1 and endogenous retroviruses in cellular
senescence, eventually leading to new therapies for this monogenic vascular dementia.

Public health relevance
Project Narrative About 40% of the human genome consists of viral DNA sequences derived from ancient retroviruses, and functions of these retroviral sequences in vascular dementia are not well understood. The TREX1 protein regulates these retroelements in our genome, and patients with inherited mutations in TREX1 develop retinal vasculopathy with cerebral leukoencephalopathy (RVCL), a vascular dementia that causes disability and premature death in 100% of affected individuals. We propose to determine how TREX1 mutants regulate genomic DNA and retroelements to cause this devastating, inherited small vessel disease of the brain.